Genomic dissection of tumor heterogeneity and progression

Project Summary The first aim of this project is to use single cell sequencing to understand the complexities of cell types and cell to cell heterogeneity that is present within pediatric solid tumors. In this work, we are focusing on generating comprehensive gene expression profiling of the cells present within tumors that occur in patients with NF1. To date we have collected and analyzed surgical specimens from Plexiform Neurofibromas (PN), Atypical Neurofibromas (AN) and Malignant Peripheral Nerve Sheath Tumors (MPNST). Over the past two years, we have generated high gene coverage sequencing on 600,000 single cells from 55 patients with NF1 nerve tumors including histologically validated PN, ANF and MPNST. Our dataset generated to date includes single-cell sequencing of PN and ANF. From these experiments, we capture the landscape of cellular heterogeneity within these tumors. Within PNs we have identified at least 21 unique cell populations including a variety of stromal and immune cell types. This rich dataset details the transcriptional profile of each of these populations and highlights both known and novel cell types. Following the same procedure, we have generated scRNAseq data from 300,000 cells from eight MPNST tumors and 10 PDX MPNST models. Preliminary examples of this dataset have been published in collaborative efforts with investigators at Memorial Sloan Kettering and Washington University. These works discovered the recurrence and importance of chromosome 8 amplification in MPNST and an interesting cellular population with cancer stem cell like properties. Additionally, we have made progress integrating the human findings with genetically engineered model systems of NF1 based nerve tumors. This initial dataset describing the multitude of cell-to-cell interactions within these tumors is accepted for publication. We also have actively been working to discover novel ways to arrest the malignant progress in these tumors. A current effort is to develop an in vitro system to understand the polarization of myeloid cell populations in the tumor microenvironment. If successful, this work could deliver specific vulnerabilities that could be used in combination with the FDA approved MEK inhibitors to further improve tumor shrinkage in patients with plexiform neurofibroma. Given the difficulty in obtaining multiple sequential tumor biopsy specimens from patients with solid tumors, we have undertaken a project to assay cell free DNA to assess disease status in NF1 patients. In this work, we have developed an assay that marries low pass whole genome sequencing with NF1 specific targeted capture deep sequencing of selected genes. This work has culminated in publication of our "classifier" which uses tumor fraction from blood specimens to provide a clinical tool that could be used to differentiate between MPNST and the benign Plexiform Neurofibroma. Currently we are evaluating our assays value using samples collected on the completed clinical trial SARC031 (NCT03433183) "MEK Inhibitor Selumetinib (AZD6244) in Combination with the mTOR Inhibitor Sirolimus for Patients With MPNST" and the ongoing clinical trial testing a CDK4 inhibitor in patients with atypical neurofibroma (NCT04750928). Another application of cell free DNA technology is correlating the changes observed in the circulating tumor DNA with the changes observed on re-staging imaging as a measure of response of a tumor to therapy. These efforts are currently underway and in the past year we have collaboratively worked with the COG soft tissue sarcoma committee to incorporated cell free DNA assays into active clinical trials. Secondary efforts to pair the circulating tumor DNA with an on-treatment tumor biopsy to observe correlation and description of the global genomic changes in the circulating tumor DNA to discover mechanisms of tumor evolution are being explored. Finally, we have continued efforts to improve the sensitivity and specificity of the cell free DNA assay. Current efforts include deeper profiling of fragment size, deeper sequencing through capture based or whole genome methods, and alternative sequencing strategies such as methylation profiling. The second aim of this work is to use the generated genomic data to develop rationally selected combination therapeutic strategies to overcome tumor heterogeneity. This work has greatly expanded over the past year and we have active efforts in relapsed refractory leukemia, PAX3-FOXO1 driven rhabdomyosarcoma, EWS-FLI1 driven Ewing Sarcoma, MYOD1 mutant rhabdomyosarcoma, and MPNST. Currently, the combination strategies are being evaluated in vitro and in vivo. In the coming year, successful candidates that show efficacy in the in vivo setting, will be evaluated for potential clinical trials.